Task B24: Production of Well Characterized Challenge Material (WCCM) of High Priority Viral Pathogens

This contract facilitates in vitro testing of potential anti-viral agents, maintenance of viral stocks and cell lines needed to grow the viruses, and development of related assays.